Advancing Nanodiamond Particles for Quantum Sensing

Summary
Single-molecule fluorescent live-cell imaging impacts translational biology by correlating individual protein
function with biological outcomes. Fluorescent nanodiamond sensors are capable of reporting on local
electromagnetic fields, free radicals, temperature, pH, and rotational orientation through nitrogen-vacancy color
centers. At molecular-level sizes (10-20 nm), however, these NV- emitters are destabilized to become inactive
and thus are not useable. In this proposal, we produce ultrasmall NDNV sensors with stabilized NV- by
fluorination and nitridation surface treatment as demonstrated by our preliminary results and guided by theory.
We use a plasma generated at atmospheric pressure through a dielectric barrier discharge to generate reactive
species that lead to surface chemical modifications at room temperature. A prototype reactor demonstrated
successful treatment of NDNV at sizes above ~50 nm. To develop ultrasmall nanodiamond-based sensors,
diamond nanomaterials from 10-40 nm size range will be functionalized by fluorination or nitridation to stabilize
NV-. In both cases, the excited state populations of the feedstock gases will be controlled by gas composition,
flow rate, and base pressure in combination with the plasma parameters. Chemical functionalization will be
verified and then correlated with optical properties which represent NV- content. Optimized candidates will then
be assessed to demonstrate changes in NV- content and quantum-relevant characteristics (T1 and T2). Because
the surfaces generated will be novel, cell viability screening to confirm that particles are consistent with
nanodiamond’s well-demonstrated biocompatibility will be also performed. To meet the growing demand as
predicted by commercialization estimates, scaled-production (grams-quantity per day) of functionalized
nanodiamond particles could be achievable by the end of phase II if successful. These ultrasmall NDNV quantum
sensors are expected to impact our understanding of disease and enable new modalities for drug and biomarker
discovery.

Public health relevance
Narrative Single-molecule fluorescent live-cell imaging is a leading technology in fundamental and translational biology correlating individual protein function with biological outcomes. Ultrasmall fluorescent nanodiamond quantum sensors will be developed for advanced single-molecule studies by chemical stabilization of sensing centers within these particles through plasma-based modification enabling sensing of local electromagnetic fields, free radicals, temperature, pH, and conformational dynamics of proteins with nanoscale resolution.